Distance Education and Training on Emerging Contaminants and Technologies (DETECT)

SUMMARY
Industrial hygienists are tasked with protecting worker health. However, there are many hazardous substances
which lack official guidelines related to their safe management. Thus, there is a need for professionals charged
with protecting worker health to be able to increase their knowledge regarding these emerging contaminants,
emerging technologies, and systems to protect worker health. This project was designed to address this need.
The Distance Education and Training on Emerging Contaminants and Technologies (DETECT) project will
implement online training modules and in-person research experiences to provide unique educational
opportunities for education on emerging contaminants and technologies for prospective graduate students,
graduate students, and industrial hygienists. The DETECT program will establish a consortium between
established programs in industrial hygiene at Purdue University, the University of Toledo, the Air Force Institute
of Technology, and the University of South Florida. The DETECT program will focus on identifying and
characterizing emerging contaminants, use of emerging technologies to assess and monitor hazardous
chemicals, and safety management systems or strategies to mitigate and prevent potential hazards. Emerging
contaminants to be discussed include, but are not limited to nanoparticles, bioaerosols, hazardous algal blooms,
and ototoxic compounds. There will be three main educational components of the DETECT program: online
educational modules, summer research sessions, and online laboratories. First, we will create a series of for-
credit and non-credit online lessons; these will be grouped together in three modules. The for-credit version of
this online educational content will be incorporated into existing industrial hygiene graduate programs at the
DETECT consortium institutions. The non-credit version will be available free of charge for anyone to access via
the Purdue Online website. Second, we will develop and run four in-person summer research sessions. Each
year, these will be hosted by a different DETECT consortium intuition and will feature a different topic.
Prospective graduate students and graduate students from the DETECT consortium institutions and beyond will
be encouraged to participate. These intensive sessions will include research training, laboratory tours, and the
opportunity for participants to complete, analyze, and present a short research project. Third, we will develop
five online laboratories and at least one virtual reality laboratory. The online laboratories will be accessible using
an internet browser, and will be incorporated into the online educational modules. The virtual reality laboratory
will be completed in-person by graduate students at the DETECT consortium institutions. Upon completion of
this project, we will have developed and implemented training in key emerging contaminants and technologies
to assess, mitigate, and prevent their impact via platforms that are accessible to a large, diverse population. This
will have a significant impact on industrial hygienists and other professionals’ ability to protect workers and the
public from health effects resulting from exposure to hazardous substances.

Public health relevance
NARRATIVE Despite notable advances in our understanding of hazardous compounds over the past century, there are many compounds or hazards for which there is little or no regulatory guidance. As industrial hygienists and those in related fields must often make immediate decisions regarding how to assess and manage these hazards on a daily basis, it is imperative that they have access to the most current information available regarding management of these hazards. In this project we will provide this information for prospective graduate students, graduate students, and career professionals via development of online courses, online laboratories, and in- person research training.